Novel Complement-targeted treatment strategies in Renal Disease

PROJECT SUMMARY / ABSTRACT
The glomerular microvasculature is a common target of dysregulated or pathologic complement (C)
activation. This has been implicated in the pathogenesis of a wide range of glomerulopathies including lupus
nephritis, membranoproliferative glomerulopathy, postinfectious glomerulonephritis and, more recently, the
atypical Hemolytic Uremic Syndrome (aHUS), and C3 glomerulopathy. Therefore, development of strategies to
minimize activation of C cascades could be promising in C-depended glomerular diseases.
The long-term goal of our research is to mitigate severity of C-mediated glomerular injury by up
regulating expression of the decay-accelerating factor (DAF), a key controller of C activation acting by
preventing assembly and accelerating decay of the naturally labile C3 and C5 convertases that amplify the
classical and alternative complement activation cascades. As there are currently no pharmacologic DAF
inducers, we sought to identify up regulators of DAF expression whose activity can be increased using existing
pharmacologic strategies or agents. We identified Heme Oxygenase (HO)-1, the inducible enzyme of heme
degradation to carbon monoxide (CO) and biliverdin, to be a DAF regulator in glomeruli. We demonstrated that
HO-1 overexpression targeted to visceral glomerular epithelial cells (also known as podocytes) upregulates
DAF and reduces C deposition and extent of injury. Owing to their non-replicative terminally differentiated
nature, podocytes are particularly vulnerable to C-mediated injury while their loss was shown to be a key
determinant of progression of glomerular diseases.
The mechanism by which HO-1 up regulates DAF in podocytes is unknown. Also unknown is the extent
to which DAF upregulation by HO-1 is critical in mitigating C-mediated podocyte injury. The proposed studies
address these questions by pursuing the following Specific Aims:
1) To identify cis-acting positive response DAF promoter elements in rat podocytes over
expressing HO-1, and examine the role of the HO reaction product, CO, as activator of specific DAF
promoter transcription factors. This Aim will test the hypothesis that increased CO production in podocytes
over expressing HO-1 up regulates DAF expression via CO responsive cis-acting positive regulatory elements
on the DAF promoter corresponding to Sp1 transcription factor binding sites.
2) To demonstrate that increased DAF expression is a key mechanism by which HO-1 mitigates
complement-dependent podocyte injury. This Aim will test the hypothesis that, in podocytes overexpressing
HO-1, DAF mediates attenuation of C-dependent injury
The experimental approach in Aim I includes use of cultured podocytes originating from Wild-Type
(WT) rats and from rats lacking HO-1 we generated using zinc-finger nuclease (ZFN)-driven HO-1 gene knock-
out. In these cells, the effect of HO-1 overexpression and of the HO reaction product, CO, on transcriptional
regulation of DAF promoter via the Sp1 transcription factor will be assessed.
The experimental approach in Aim II includes use of a rat model of antibody-mediated C-dependent
podocyte injury resembling human membranous nephropathy, which will be induced in rats with podocyte-
targeted HO-1 overexpression we generated using sleeping beauty (SB) transposon-mediated transgenesis
that are either DAF replete or DAF deficient.
Observations from the proposed studies are expected to have positive translational impact because the
demonstration that HO-1 minimizes C-mediated injury via DAF induction could lead to novel strategies for
therapeutic interventions in C-dependent renal diseases.

Public health relevance
Project Narrative Complement (C) is a system of interacting proteins that provides host defense by destroying microbes and strengthening immunity. However, abnormal regulation or pathologic activation of these proteins can destroy host cells and organs. A number of diseases can be caused by such dysregulation and include kidney diseases that can evolve to an irreversible stage referred to as Chronic Kidney Injury (CKD). CKD kills more Veteran's than cancers of breast and prostate cancer combined. These dismal observations point to a critical need for innovation to prevent and treat CKD. This basic Research Proposal aims to find ways of minimizing C-mediated kidney injury by boosting a physiologic inhibitor of C activation known as Decay-Accelerating Factor (DAF). Efficacy of proposed strategies will be tested in kidney cells and an animal model of C-mediated kidney injury.